Mechanisms of metabolic reprogramming by PIK3CA oncogenic mutations

The goal of this competitive renewal is to interrogate a paradigm-shifting hypothesis that a combination of CB-
839, a glutaminase inhibitor, and 5-FU induces neutrophil extracellular trap (NET) in PIK3CA mutant colorectal
cancers (CRCs), which in turn kills these cancer cells. NETs are extracellular web-like structures of cytosolic and
granule proteins assembled on de-condensed chromatin. NETs trap and kill bacteria, fungi, viruses, and
parasites. Although some studies implicate NETs in tumor metastasis, whether NETs can kill cancer cells is
largely unexplored. This proposal is built on the novel findings that we made during the current funding period:
1) PIK3CA mutations render CRCs more dependent on glutamine; 2) CB-839 preferentially inhibits xenograft
growth of PIK3CA mutant CRCs; 3) the combination of CB-839 with 5-FU induces xenograft tumor regression of
PIK3CA mutant CRC in nude mice; 4) the combination of CB-839 and 5-FU preferentially induces NETs in
PIK3CA mutant CRCs; 5) depletion of neutrophils in nude mice significantly attenuates the efficacy of the drug
combination; 6) disruption of NETs by DNase I treatment in xenograft tumors also attenuates the efficacy of the
drug combination. These exciting observations lead us to hypothesize that NETs induced by the drug
combination kill PIK3CA mutant CRCs. Two aims are proposed to test this exceptionally novel hypothesis. Aim
1 will determine if the combination of CB-839 and 5-FU induces NETs in immune-competent mice and human
CRC patients. Aim 2 will elucidate the mechanisms by which NETs kill PIK3CA mutant CRCs. Although we focus
on colon cancer in this proposal, our proposed studies may have a broader impact beyond colorectal cancer
because PIK3CA is mutated in ~ 20% of all human cancer. Moreover, the mechanisms identified in the study
may also apply to other NET-related diseases.

Public health relevance
Colorectal cancer is the second most common cause of cancer deaths in the United States, with 150,000 new cases and 55,000 deaths per year. Our proposed studies will provide novel understanding to how cancer cells become dependent on an amino acid called glutamine. Most importantly, we will investigate whether deprivation of glutamine in cancer cells by a drug will starve cancer cells to death, thereby providing a novel therapy to treat colorectal cancer patients.